Open data-driven infrastructure for building biomolecular force fields for predictive biophysics and drug design

PROJECT SUMMARY/ABSTRACT The study of biomolecular interactions and design of new therapeutics requires accurate physical models of the atomistic interactions between small molecules and biological macromolecules. Over the least few decades, molecular mechanics force ﬁelds have demonstrated the potential that physical models hold for quantitative biophysical modeling and predictive molecular design. However, a signiﬁcant technology gap exists in our ability to build force ﬁelds that achieve high accuracy, can be systematically improved in a statistically robust manner, be extended to new areas of chemistry, can model post-translational and covalent modiﬁcations, are able to quantify systematic errors in predictions, and can be broadly applied across a high-performance software packages. In this project, we willl bridge this technology gap to enable new generations of accurate quantitative biomolec- ular modeling and (bio)molecular design for chemical biology and drug discovery. In Aim 1, we will produce a modern, open infrastructure to enable practitioners to rapidly and conveniently construct and employ accurate and statistically robust physical force ﬁelds via automated machine learning methods. In Aim 2, we will construct open, machine-readable experimental and quantum chemical datasets that will accelerate next-generation force ﬁeld development. In Aim 3, we will develop statistically robust Bayesian inference techniques to enable the auto- mated construction of type assignment schemes that avoid overﬁtting and selection of physical functional forms statistically just?ed by the data. This approach will also provide an estimate of the systematic error in predicted properties arising from uncertainty in parameters or functional form choices—generally the dominant source of error—to be quantiﬁed with little added expense. In Aim 4, we will integrate and apply this infrastructure to produce open, transferable, self-consistent force ﬁelds that achieve high accuracy and broad coverage for modeling small molecule interactions with biomolecules (including unnatural amino or nucleic acids and covalent modiﬁcations by organic molecules), with the ultimate goal of covering all major biomolecules. This research is signiﬁcant in that the technology developed in this project has the potential to radically transform the study of biomolecular phenomena by providing highly accurate force ﬁelds with exceptionally broad chemical coverage via fully consistent parameterization of organic (bio)molecules. In addition, we will produce new tools to automate force ﬁeld creation and tailoring to speciﬁc problem domains, quantify the systematic error in predictions, and identify new data for improving force ﬁeld accuracy. This will greatly improve our ability to study diverse biophysical processes at the molecular level, and to rationally design new small-molecule, protein, and nucleic acid therapeutics. This supplement to the original RO1 is to purchase a small GPU cluster to enable rapid prototyping of many of the approaches that are proposed in this project outlined in the four aims.

Public health relevance
PROJECT NARRATIVE Scientists use computer simulations of proteins, DNA, and RNA, at atomic detail, to learn how these molecules of life carry out their functions and to design new medications. We aim to greatly increase the utility of all of these simulations by improving the accuracy of the formulas they use to compute the forces acting between atoms. This equipment supplement will provide computational resources for testing of new techniques throughout the duration of the grant.